Project 3: Methods for Selective Extraction, Concentration and Detection of N-Nitrosamines

PROJECT SUMMARY/ABSTRACT – PROJECT 3
N-nitrosamines include some of the most mutagenic chemicals known to humankind, and they are present at
and near Superfund Sites, in drinking water, and in food and drugs. What is needed are new methods to detect
N-nitrosamines in water that can be used to enable distributed sensing. A major limitation in informing risk of
exposure is the fact that N-nitrosamine detection requires sophisticated laboratory equipment in centralized
locations. These methods, although highly accurate, are expensive and require trained technical staff. The goal
of this project is to create materials and methods that are sufficiently inexpensive to be performed routinely by
individuals without the need for detailed technical training. Specific Aim 1 is to create and deploy porous
absorptive polymer films and particles with recognition elements specific for N-nitrosamines.
Recognition containing solid phase extraction materials can be used to concentrate N-nitrosamines from water.
Under conditions where N-nitrosamines are detected, Project 3 then contributes to the identification of which N-
nitrosamines are present, to be done via conventional centralized laboratory determinations (to be developed by
Project 4). Knowing which N-nitrosamines are present will guide studies of biological impact to be done by Project
1 and Project 2. Specific Aim 2 is to create and apply a novel NDMA optical sensor that exploits NDMA
fragmentation products. The solid phase extraction materials also serve as a platform for field-deployed
sensing systems. The detection mechanisms make use of photolytic breakdown of N-nitrosamines that can be
conducted in solution or directly in solid phase extraction materials. Reactive species generated by photolysis
allow for detection by additional reactions to organic aromatic molecules that can be used to create new emissive
species or highly colored materials. Additionally, reactive species generated photolytically can be used to create
chemiluminescence. Specific Aim 3 is to create a field-deployable device effective for use by community
members to perform Citizen Science. The new optical based sensing methods given will be evaluated for
sensitivity, accuracy, resistance to interfering species, and the ability to be translated to methods appropriate for
use by community members. Providing sensing methods will be facilitated by leveraging smartphone cameras
as detectors. Smartphone methods can be used in both colorimetric and emissive detection methods. With
support from the CEC, empowering communities to frequently detect N-nitrosamines in their environment and
water supplies will help to create a more comprehensive understanding of risk and how seasons, weather, and
human interventions impact the exposure risks. Trainees will drive the research and will be supported by the
Research Experience and Training Coordination Core, and research translation will be fostered by the
Administrative Core. Results on which N-nitrosamines are present will be combined by the Data Management
and Analysis Core with new understanding of biological impact to contribute to our comprehension of risk for
specific water samples.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 N-nitrosamines are probably human carcinogens that are present not only at Superfund Sites, but also in the municipal water that is used by the Passamaquoddy Tribe, making it imperative that the NIEHS Superfund Research Program enable problem-based solution-oriented research on N-nitrosamines using cutting edge technologies. This project will provide improved methods for the detection of toxic N-nitrosamines in water and make the methods available to affected communities. Specifically, materials that absorb N-nitrosamines will be developed to improve detection, and easy-to-use field-deployable detection methods will be developed that exploit smartphone technology.